A trial of transplanting Hepatitis C-viremic kidneys into Hepatitis C-Negative kidney recipients (THINKER-NEXT)

Project Summary/Abstract
Kidney transplant extends life, improves quality of life, and reduces healthcare costs. Unfortunately, the waiting
list exceeds 94,000 people while only approximately 14,000 deceased donor kidney transplants (DDKT) occur
annually and many patients wait >5 years for a DDKT. For the elderly and some other patient groups, it is
common to die waiting. Yet, nearly 600 kidneys from donors infected hepatitis C virus (HCV) were discarded in
2018 (50.1% of the total number of kidneys from HCV-viremic donors); hundreds more kidneys are never
procured because of the perception that no center will accept them. Early successes of pilot clinical trials and
single-center series of transplanting kidneys from HCV-viremic donors have demonstrated the potential for this
practice to increase the number of lifesaving kidney transplants by more than 1,000 kidney transplants each
year. However, the dominant system for assessing kidney quality also applies a lower quality score to any
kidney from an HCV-viremic donor, thereby promoting organ discard. Also, early experiences from
uncontrolled studies without well-matched comparator groups has led to reports of unexpected complications
and/or higher than anticipated rates of treatment failures that underscore the need for a formal multi-center
clinical trial. Recent reports have highlighted a series of post-transplant complications that necessitate
evaluation in a large multi-center trial, for example: a) fibrosing cholestatic HCV in several HCV-negative
recipients of an HCV-viremic donor; b) increased incidence of CMV viremia in recipients of HCV-viremic
kidneys; and c) membranoproliferative glomerulonephritis. While these complications are rare, they underscore
the view from transplant leaders, including the American Society of Transplantation, the American Association
for the Study of Liver Diseases, and the Infectious Disease Society of America that this practice is considered
`experimental' and is best performed under IRB-approved protocols with rigorous informed consent and
assurances of access to HCV treatment. Furthermore, despite increased transplantation of kidneys from HCV-
viremic donors into HCV-negative patients, there remain persistent knowledge gaps that need to be addressed
for this practice to be accepted as routine clinical care from the perspective of patients, providers, and payers.
This multi-center trial seeks to provide significant knowledge gaps that remain by addressing these specific
aims: a) estimate HCV cure rates in HCV-negative recipients of HCV-viremic kidneys with a narrow confidence
interval; b) determine whether consenting to receiving an HCV-viremic kidney improves survival; c) evaluate 1-
year renal function of HCV-viremic kidneys compared to matched comparators; d) assess whether HCV-
negative recipients of HCV-viremic kidneys have increased risks of CMV infection; and e) determine if the
prevalence of chronic kidney disease pathology is similar in HCV-viremic vs HCV-negative kidney donors. The
overarching goal is to determine if kidneys from HCV-viremic donors can safely be transplanted into HCV-
negative patients with end-stage renal disease.

Public health relevance
Project Narrative The practice of transplanting kidneys from hepatitis C virus (HCV) infected donors into patients without HCV is considered `experimental' by many leaders in the transplant field because of limited information about risks and benefits. Specifically, when patients consider accepting a kidney from a donor with HCV infection, their doctors are not able to provide good information about key issues, including: the risks of not being cured of HCV, whether choosing to accept these kidneys is likely to improve their survival, the long-term function of these kidneys after transplantation, and whether there are additional infectious risks such as developing complications from viruses other than HCV. This multi-center trial seeks to define the safety and determine the most important outcomes after transplanting kidneys from HCV-viremic donors into HCV-negative patients in order to move the practice from experimental to routine clinical care from the perspective of patients, providers, and payers.